Screening for Cys-Reactive Ligands to Target PAX3-FOXO1

Supplemental application U54 CA231630 PI: Angela Koehler, Co-PIs: Sara Buhrlage, Jarrod Marto
Abstract
Alveolar rhabdomyosarcoma (ARMS) is a lethal pediatric cancer driven by the oncogenic
transcription factor fusion protein PAX3-FOXO1 (P3F). While genetic data demonstrate P3F is a
potential therapeutic target, transcription factors are often considered challenging pharmalogical
targets. The goal of this U54 supplement is to expand drug identification strategies past our
current small-molecule microarrays (SMMs) and implement covalent ligand screening against
P3F protein Cys residues, thus increasing the pool of potential drug candidates. To achieve this
goal, team will collaborate to pursue three objectives. First, Dr. Koehler’s team will increase
production of purified full-length P3F as well as truncated forms of the protein which contain
Cys-793, a residue identified as a critical mediator of cofactor CBP. Second, Dr. Koehler’s team
will work with Drs. Buhrlage and Marto to optimize screening conditions for a full cys-reactive
library utilizing a pooling-approach to increase throughput. Individual hits will be validated
through LC-MS/MS to confirm biochemical results, such as covalent modifications and
stoichiometry. Lastly, covalent ligand screen hits will be subjected to secondary assays, such as
cellular thermal shift or reporter assays, outlined in the parent U45 for SMM drug discovery.
This collaboration between Dr. Koehler and Drs. Buhrlage and Marto will expand the U54
team’s drug discovery capabilities, and enable a more thorough and efficient assessment of
candidate drugs to target P3F. In the future, this technological approach could be extended to
other transcription factors for drug candidate identification.

Public health relevance
Supplemental application U54 CA231630 PI: Angela Koehler, Co-PIs: Sara Buhrlage, Jarrod Marto Narrative This U54 supplement proposal outlines a collaboration between the laboratory of Dr. Koehler, who helped conduct drug target screens for PAX3-FOXO1 (P3F) and is a current member of the U54 team, and Dr. Buhrlage and Dr. Marto, new U54 team members and scientists at the Center for Emergent Drug Targets at the Dana-Farber Cancer Institute. This proposal compliments current small-molecule microarray strategies outlined in the parent U54 and expands drug discovery efforts to include covalent ligand screening of P3F Cys residues. Successful completion of the proposed project will increase the pool of potential small molecule drug candidates to target P3F, directly supporting the ultimate goal of identifying new drug candidates to treat alveolar rhabdomyosarcoma. This supplement is innovative as this collaboration further diversifies the U54 team’s expertise, reinforces the translational research efforts, and extends our previously proposed work of Projects 2 and 3.